Inline Analysis of Phosphates in Fluids

Project Summary/Abstract
The goal of this project is to develop a sensor for monitoring orthophosphates in wastewater to enable efficient
treatment through data-driven implementation of process control strategies. Nutrient pollution from human
activities, such as agriculture, sewage, and lawn fertilization, accelerates eutrophication, threatening estuaries,
wetlands, and freshwater ponds across the U.S. This results in harmful algal blooms (HABs) that pose a potential
risk to human health. The proposed sensor is based on novel molecular imprinted polymers (MIPs) that are
sensitive and selective to orthophosphates. Combined with infrared absorption spectroscopy, the
orthophosphates can be monitored inline in environmental settings, as well as wastewater treatment plants,
enabling optimization of wastewater treatment strategies.

Public health relevance
Project Narrative Inline analysis of orthophosphates in wastewater is critical for ensuring treatment quality and implementing efficient process control strategies at wastewater treatment plants. The public health relevance of the proposed sensor technology for monitoring orthophosphates is its potential to enable efficient screening of treatment quality and prevention of orthophosphates transport to environmental water sources, where the accumulation of excess nutrients triggers harmful algal blooms (HABs) that pose a potential risk to human health.